MIR182 and Ocular Hypertension.

Abstract
Despite the significant research effort of microRNAs (miRNAs) in the pathogenesis of glaucoma, their
specific roles in the aqueous outflow pathway remain unclear. Lowering intraocular pressure (IOP) is the only
clinical treatment for primary open-angle glaucoma (POAG), no matter whether the patients have high (IOP > 21
mmHg) or normal-tension glaucoma (IOP ≤ 21 mmHg). Significant achievements have been made in
understanding the regulation of IOP and identifying therapeutic targets to lower IOP. We and others have
identified the association of rs76481776 in the MIR182 gene with POAG. However, it remains unknown how
miR-182-5p contributes to POAG risk. Without such knowledge, the development of miRNA-based glaucoma
therapy will likely remain difficult. Our overall objective is to determine how elevated expression of miR-182-5p
contributes to POAG with high IOP. The risk allele A of POAG-associated rs76481776 with POAG has been
reported to increase mature miR-182-5p expression in vitro, suggesting that elevated miR-182-5p expression
may contribute to POAG. We identified 2-fold higher miR-182-5p expression in glaucomatous aqueous humor
compared to controls. Our central hypothesis is that elevated expression of miR-182-5p affects IOP by regulating
the cellular functions of human trabecular meshwork (TM) and Schlemm's canal (SC) endothelial cells. Human
TM cells with induced premature senescence have 7-9 fold higher miR-182-5p expression, and overexpression
of miR-182-5p in these HTM cells leads to partial cellular senescence. miR-182-5p has been shown to target
genes in many pathways, such as CHEK2, FOXO1, MTSS1, and CYLD. The expression of miR-182-5p could
be induced by TGF-β treatment in cancer cells, leading to prolonged NF-κB activation, while TGF-β related
pathways have been shown to play essential roles in POAG and fibrosis. The rationale for this proposal is that,
once we determine how elevated miR-182-5p expression affects the cellular functions of human TM and SC,
certain genes or miRNAs could be manipulated either up or down pharmacologically, resulting in new and
innovative approaches to lower IOP and to delay/prevent the progression of glaucoma. In Aim 1, we will identify
molecular targets of miR-182-5p in primary human TM cells in vitro. Human TM cells will be subject to cyclic
mechanical stretch and tissue train 3D cell culture with uniaxial tissue stretch. We will perform whole proteomics
profiling and strand-specific RNA-Seq analysis to identify miR-182-5p target genes. In Aim 2, we will determine
the impact of miR-182-5p overexpression in the TM and SC on outflow facility and IOP levels in vivo using
transgenic mice. Upon successful completion, we expect to identify the specific molecular targets of miR-182-
5p in human TM and SC to lower IOP more effectively in glaucoma patients.

Public health relevance
Project Narratives The goal of this proposal is to determine how the increased expression of a small noncoding RNA miR- 182-5p in the front part of human eyes contribute to elevated eye pressure and glaucoma risk. Eye pressure is the major and only treatable risk factor with glaucoma patients in the clinic. The successful completion of this project will help uncover critical information on the specific roles of miR-182-5p and its molecular targets in regulating eye pressure and provide new treatment targets to lower eye pressure more effectively in glaucoma patients.